Envelope biogenesis in Gram-negative bacteria

PROJECT SUMMARY
Bacteria interact with the outside world through their cell envelope. The cell envelope defines cell boundaries
and provides structural integrity and cell shape to bacteria. Therefore, properly building their multi-structure
envelope is critical to ensure growth and survival. In Gram-negative bacteria, the cell envelope is delimited by
two lipid bilayers, the inner membrane and the outer membrane. These membranes are separated by an
aqueous compartment known as the periplasm, which also contains a thin peptidoglycan cell wall. The structure
and composition of the Gram-negative outer membrane is unusual mainly because it is not a phospholipid
bilayer. Its inner leaflet contains glycerophospholipids, but its outer leaflet is composed of lipopolysaccharides
(LPS). By densely packing their cell surface with LPS molecules, Gram-negative bacteria create a permeability
barrier against small hydrophobic molecules that otherwise could diffuse across phospholipid bilayers.
Consequently, these bacteria are naturally resistant to many antibiotics and detergents. The long-term plan of
our research program is to investigate how Gram-negative bacteria build their cell envelope. This project focuses
on understanding outer membrane biogenesis by studying the mechanism of function of lipid transporters that
build this bilayer. Outer-membrane lipids are synthesized in the inner membrane, so they must travel through
the aqueous periplasmic compartment and be asymmetrically delivered to the outer membrane. The proposed
research plan will leverage our expertise in applying genetic and biochemical approaches to study the cell
envelope in order to investigate two highly conserved systems that are essential for outer-membrane biogenesis
and growth of the Gram-negative bacterium Escherichia coli. We will investigate how the Lpt system extracts
newly synthesized LPS molecules from the inner membrane and transports them across the cell envelope
through a protein bridge so that they can be assembled at the cell surface. Our studies will focus on how LPS
extraction and transport are powered by the LptB2FGC components, which constitute an ATP-binding cassette
(ABC) transporter at the inner membrane. ABC transporters are ATP-driven machines that all cells use to move
substrates across cellular compartments. We will also investigate transport of phospholipids from the inner to
the outer membrane by newly discovered bridge-like proteins belonging to the AsmA-like protein family. These
proteins have recently been recognized as the bacterial ancestors of lipid-transfer proteins that transport
phospholipids at contact sites between membranes of different organelles in eukaryotic cells. Our research will
therefore provide fundamental knowledge about bacterial physiology and growth that is also applicable to
homologous systems conserved across many organisms. In addition, since the barrier imposed by the outer
membrane is the main reason why very few novel antibiotics effective against Gram-negative pathogens have
been developed in decades, the knowledge obtained from our research will contribute to the development of
novel antimicrobials.

Public health relevance
PROJECT NARRATIVE This project will investigate how Gram-negative bacteria transport lipids across their envelope to build their outermost layer, the outer membrane. Our work will generate fundamental knowledge about the mechanism of function of transporters that are potential targets for new antibiotics. In the long term, this knowledge will help in the development of much needed novel antimicrobials that can treat infections caused by Gram-negative bacteria, which pose a serious threat to global health.